Role of GSK3beta Subcellular Localization in AML Stemness

?DESCRIPTION (provided by applicant): Acute myeloid leukemia (AML) is an aggressive disease with poor survival and antiquated treatments poorly tolerated the elderly. Current leukemia treatment fails to kill non-dividing, leukemia stem cells, which promote relapse post-remission. For this reason, understanding the biology of these stem cells is of great interest to the field. GSK3β is a serine/threonine kinase that affects several pathways critical for cancr development. GSK3β degrades β-catenin, a key promoter of AML stem cells, and activates NF-κB, a key protein promoting AML proliferation and survival. Preliminary studies show GSK3β is elevated and more nuclear in AML. This nuclear GSK3β more potently suppresses leukemogensis in vivo and more potently activates NF-κB signaling than cytoplasmic GSK3β. We observe that AML non-stem cells express more nuclear GSK3β than AML stem cells, and hypothesize that this increased nuclear GSK3β may shift cells from a β-catenin-driven, self-renewing stem phenotype to a more NF-κB-driven, proliferative, non-stem phenotype. We will study the implications of GSK3β nuclear subcellular localization in AML by assessing its anti-β-catenin and pro-NF-κB effects, defining a specific mechanism of action for each effect. We will show high nuclear GSK3β specifically inhibits AML stem cell formation and maintenance, leading to less AML proliferation, colony formation, and mouse engraftment. We will show moderate levels of nuclear GSK3β promote AML progression in vivo. Finally, we will test if GSK3β levels, activity, and localization in AML stem cells or non-stem cells correlate to better overall survival and/or complete remission, predicting more nuclear GSK3β correlates with a more positive prognosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: We seek to understand leukemia development by looking at how the cellular location of a key protein changes as the leukemia evolves. We seek to link this protein to key cellular machinery that helps immortalize the cell. Through this understanding, we better define why our key player is a promising target for leukemia therapy.